Defining the Impact of Biological Sex and Sex Hormones on Epithelial and Immune Cell Transcriptomics and HIV Transmission in Human Rectal Tissues

While many individuals possess variations in their sex hormone milieu related to medical conditions, surgeries,
or medication use, there are critical knowledge gaps in our mechanistic understanding of the effects of sex
hormones on the rectal mucosal environment, a critical site of vulnerability to HIV infection. This is of
paramount importance, as biological sex and sex hormones mediate effects on epithelial and immune cell
function through their influence on transcriptional activity of the cell, and these effects could alter the
susceptibility of the rectal mucosa to HIV infection. The Specific Aims of this proposal are to compare sexspecific, spatially localized gene expression patterns of rectal mucosal immune and epithelial cell
subpopulations between men and women utilizing spatial transcriptomics integrated with single cell RNA
sequencing (Aim 1), to define the single cell transcriptomic signatures of rectal mucosal cellular subsets from
men and women following ex vivo sex hormone exposure (Aim 2), and to use the HIV explant challenge model
to examine the effects of ex vivo sex hormone treatment on rectal tissue susceptibility and host immune
responses to HIV (Aim 3). This research strategy will facilitate a 5-year career development and training plan
that will enable Dr. Grimsley Ackerley to build upon her prior research experience and gain critical mentored
research training in: 1) Bioinformatics and Transcriptomic Data Analyses, 2) Mucosal Immunology and HIV
transmission, and 3) the Conduct of HIV Prevention Research. To achieve these training aims, Dr. Grimsley
Ackerley has assembled a multidisciplinary mentorship team with expertise in mucosal immunology, sex
hormone biology, single cell and spatial transcriptomic technologies, HIV prevention research, and
biostatistics. This proposal will capitalize on a robust research environment at Emory University and will be
supported by resources available through The Hope Clinic of the Emory Vaccine Center and the Emory
National Primate Research Center.
Dr. Grimsley Ackerley’s long-term career goal is to lead a successful and independent translational mucosal
immunology program that specializes in the use of genomics applications and the ex vivo HIV explant
challenge model to better understand biologic and immunologic factors that influence mucosal HIV
susceptibility among people who have an increased likelihood of acquiring HIV. Achievement of this long-term
goal will be made possible through the completion of the proposed K23 research aims and training plan, along
with the support garnered from the highly experienced mentorship team. This proposal will begin to address,
mechanistically, the effects of biological sex and sex hormones on the rectal mucosal environment and rectal
HIV susceptibility. The data generated will serve as the foundation for future NIH R-level funding to facilitate
Dr. Grimsley Ackerley’s transition to an independent clinical-translational research career in the field of HIV prevention science.

Public health relevance
Sex hormone concentrations among men and women, including levels of estrogens and androgens, vary throughout the lifespan, and may be altered as a result of certain medical conditions, surgical procedures, or medications; yet, little is known about how changes in sex hormone levels may impact HIV transmission at mucosal sites. In this proposal, we will examine the effects of biological sex and sex hormone milieu on rectal mucosal epithelial and immune cell transcriptomic diversity and function, and we will assess the impact of sex hormones on rectal mucosal immune responses and HIV susceptibility. A better understanding of sex hormone effects on rectal HIV transmission could contribute to the development of biomedical HIV prevention interventions that are tailored to different hormonal contexts and directly benefit individuals with increased vulnerability to HIV acquisition.